PREPARATION OF RESEARCH PAPERS ON SYRIAN HAMSTER SYSTEM

The goal of this contract is to have Dr. Tu, the former Principal Investigator, analyze the data previously derived from the research conducted under contract N01-ES-65151, and prepare and submit five manuscripts for publication in scientific literature to detail the attempts to improve the assay.